The role of subcortical inputs to the hippocampal CA3 region in fear memory

PROJECT ABSTRACT
The hippocampus is essential for memory formation and spatial navigation. In the classic hippocampal
trisynaptic circuit (entorhinal cortex→dentate gyrus→CA3→CA1), dentate gyrus and CA1 act as the primary
input and output areas, respectively, that connect the hippocampus with the brain areas outside of the
hippocampus. By contrast, CA3 is often viewed as an auto-associative network vital for contextual learning via
its intra-hippocampal connections. While CA3’s intra-hippocampal inputs and outputs, including mossy fibers
from dentate gyrus, recurrent collaterals from CA3, and Schaffer collaterals to CA1 have been extensively
studied, the connections between CA3 and other subcortical areas remain largely unexplored. This proposal
aims to fill this critical gap of knowledge by investigating the functional connectivity and behavioral roles of
subcortical-to-CA3 inputs. Our preliminary experiments revealed that two subcortical areas outside of the
hippocampus – basolateral amygdala and supramammillary nucleus in the hypothalamus – excite and inhibit
CA3 pyramidal neuron activity, respectively. We will, therefore, test a central hypothesis that basolateral
amygdala and supramammillary nucleus promote and suppress contextual fear learning by enhancing and
suppressing the activity of CA3 pyramidal neurons, respectively. In Aims 1 and 2, we will determine whether a
selective population of neurons in basolateral amygdala and supramammillary nucleus excite and inhibit CA3
pyramidal neuron activity in vitro and in vivo, respectively. In Aim 3, we will determine the role of basolateral
amygdala-CA3 and supramammillary nucleus-CA3 inputs in contextual fear memory. The proposed studies
represent a significant shift of focus from traditional research on CA3’s intra-hippocampal connectivity to its
extra-hippocampal connectivity. Furthermore, as impairments of CA3, basolateral amygdala, and
supramammillary nucleus are strongly associated with many neuropsychiatric disorders, including
posttraumatic stress disorders (PTSD), depression, chronic stress and epilepsy, this proposal will provide a
valuable knowledge base for future studies to explore the role of these three interconnected regions in disease.

Public health relevance
PROJECT NARRATIVE The proposed research aims to determine the functional connectivity and behavioral roles of subcortical-to- hippocampal CA3 projections, including the basolateral amygdala-to-CA3 and supramammillary nucleus-to- CA3 inputs. Given the strong involvement of CA3 in a range of neurological and psychiatric disorders, such as posttraumatic stress disorders (PTSD), depression, chronic stress, and epilepsy, the knowledge gained from this proposal will provide novel insights into its normal functions and provide a foundation for future studies to explore the role of these pathways in mental disorders.